Rapid Tests for Recent Infection (RTRI) for Precision Public Health in Sub-Saharan Africa: Next-Generation Strategies Amid Changing HIV Epidemiology

ABSTRACT/SUMMARY
HIV is a leading cause of death in sub-Saharan Africa (SSA), but rates of new infections in declining. As a result,
some HIV services are becoming less efficient: HIV prevention is averting fewer infections per client served, and
HIV testing yield (i.e., the fraction of tests leading to new diagnoses) is declining. Given resource constraints,
HIV prevention and testing programs will need to increase efficiency in order to maintain momentum toward
epidemic control. Specifically, a precision public health approach could be used to focus services where their
health benefits would be greatest. Precision public health has been challenging to implement in SSA’s
generalized HIV epidemics because most transmission is not confined to identifiable key populations, eluding
precise responses. Until recently, the only tool for describing HIV transmission has been phylogenetic analysis
of HIV genome sequences, which is too slow and costly for real-time response at scale. Rapid tests for recent
HIV infection (RTRI) recently became available in SSA, offering a novel opportunity to identify active transmission
clusters and respond with precision. RTRI detects high-avidity antibodies that appear approximately one year
after HIV infection. If only low-avidity antibodies are detected, this infection likely occurred in the past year.
Zambia is an early adopter of RTRI and followed-up two-thirds of positive HIV tests with RTRI in 2021. Despite
the large scale of Zambia’s RTRI program, it has not been evaluated in terms of impact or cost-effectiveness,
and outbreak response thresholds have not been optimized. However, the wealth of data now collected by the
RTRI program could guide higher-performing, next-generation outbreak response strategies. Our team has
expertise in Zambian HIV policy, program implementation, health economics, bioethics, geospatial analysis,
machine learning, and infectious disease modeling. We helped to develop the only HIV social network model
rigorously validated to predict HIV incidence, prevalence, and transmission patterns in SSA, which has been
used for international and country-level HIV policy decision-making for over a decade. We propose to partner
with the Center for Infectious Disease Research in Zambia (CIDRZ), a Zambian-run NGO that has been
supporting MoH for over a decade in HIV policy-making and implementation (including RTRI), to (Aim 1)
determine whether the RTRI program can help Zambia achieve its epidemic control goals, (Aim 2) measure the
cost and estimate the cost-effectiveness of the RTRI program, and (Aim 3) use “big data” methods to design
next-generation outbreak responses, taking into account trade-offs of sensitivity vs. specificity, precision vs.
ease-of-use, and precision vs. avoidance of collecting potentially stigmatizing data elements. While pursuing
scientific Aims and hypotheses aligned with the NOSI “Harnessing Big Data to Halt HIV”, we will also have direct
policy impact by providing real-time analytics, HIV outbreak mapping, and input for RTRI policy decision-making.

Public health relevance
PROJECT NARRATIVE HIV is a top cause of death in sub-Saharan Africa, but rates of new infections are declining, so that HIV prevention services avert fewer infections per client served, and HIV testing services lead to fewer new HIV- positive diagnoses per test conducted. To increase the efficiency of these services, a rapid point-of-care test for recent HIV infection has been developed and is being used in over two-thirds of people newly diagnosed with HIV in Zambia in order to identify other people at risk or living with undiagnosed HIV in their social networks. We will use mathematical modeling to determine whether recency testing can help Zambia achieve epidemic goals, is a good use of limited resources, and can be improved upon using “big data” methods for greater precision, ease-of-use, and avoidance of potentially stigmatizing data elements.